Autonomic remodeling and modulation as mechanism and therapy for sudden cardiac death in heart failure

Sudden cardiac death (SCD) from lethal heart rhythms (ventricular tachyarrhythmias; VT/VF) claims more lives
each year in the United States than all disease-related causes of death combined. Patients with heart failure
(HF) have the highest SCD risk. Poor understanding of underlying mechanisms linking HF and SCD preclude
design of new, more effective therapies. The foremost limitation for mechanistic studies of SCD has been the
lack of a suitable, non-genetic experimental model with key features of human HF. We have developed a novel
model that fulfills these criteria and showed that maladaptive β-adrenergic (β-AR) responsiveness results in
increased cardiac mitochondrial reactive oxygen species (ROS), leading to calcium derangement, decreased
cardiac function, and increased VT/VF and SCD. Previous studies performed by our lab show that (1) failing
hearts exhibit decreased β-AR responsiveness and poor electrical stability which can be reversed through
activation of parasympathetic (i.e. muscarinic) receptors, and (2) increased ROS levels are directly linked to poor
cardiac function and SCD can be prevented through ROS scavenging.
Chronic vagus nerve stimulation (VNS) is a promising new therapy for improving left ventricular (LV) function in
clinical trials of HF patients. However the underlying mechanisms for chronic VNS are largely unknown.
Furthermore, the effect of chronic VNS on SCD has yet to be studied. While acute VNS terminates arrhythmia,
chronic VNS may prolong cardiac repolarization and predispose to arrhythmias, especially in HF patients who
typically have prolonged electrocardiographic QT intervals. Establishing whether chronic VNS is truly a safe
approach for treating HF in humans remains an important task.
Our preliminary findings revealed that although chronic VNS did prolong the electrocardiographic QT interval,
animals treated with chronic VNS displayed decreased QT interval heterogeneity and SCD incidence. To
determine if chronic VNS confers its salutary effects by way of ROS or muscarinic-related mechanisms, we will
test the hypothesis that chronic VNS prevents VT/VF and SCD by reducing calcium derangement, energy
demand, oxidative stress, and autonomic dysfunction in LV myocytes during pressure-overload cardiac
stress. Our hypothesis will be tested pursuant to the following aims:
Aim 1: Determine the effect of chronic VNS on autonomic balance, HF, VT/VF and SCD
Aim 2: Determine the effect of chronic VNS on oxidative stress, energetics, and workload in failing LV myocytes
Aim 3: Determine the effect of chronic VNS on electromechanical coupling and SCD risk in excised whole hearts
Thus far, we have shown that chronic parasympathetic signaling represents a novel approach for treatment of
SCD. This highly impactful project will allow us to (1) improve upon delivery of chronic VNS for HF treatment,
(2) provide a novel, effective therapy for SCD treatment where none currently exist, and (3) generate new
avenues of research through direct targeting of the underlying mechanisms for chronic VNS, SCD, and HF.

Public health relevance
Project Title: Autonomic remodeling and modulation as therapy and mechanism for sudden cardiac death and heart failure Project Narrative: Over 300,000 Americans die each year from sudden cardiac death (SCD) due to a lack of effective treatment options. Though application of chronic vagus nerve stimulation (VNS) as a heart failure (HF) therapy has shown beneficial effects in clinical trials, its effect on SCD has yet to be studied, and the underlying mechanisms for both SCD and chronic VNS remain unclear. Understanding how chronic VNS effects SCD risk will (1) provide insight into the molecular and cellular mechanisms for chronic VNS as well as SCD, (2) improve upon current VNS treatment methods in HF, and (3) better enable development of targeted therapies designed to reduce the high mortality associated with SCD.